Strengthening Training and Research Initiatives for Vietnam to Effectively Managing Non-Communicable Diseases (STRIVE-NCD)

Summary. We propose a renewal training program entitled “Strengthening Training and Research
Initiatives for Vietnam to Effectively Managing Non-Communicable Diseases (STRIVE-NCD)” Our initial
training program in partnership with Hanoi Medical University (HMU), the Vietnamese Ministry of Health (VMOH),
and UMass Chan Medical School made significant inroads in strengthening NCD research capacity in Vietnam.
Nonetheless, the VMOH expressed the need for continued partnership to strengthen research capacity in the
clinical and population health sciences. We will expand our existing program to other areas identified by the
VMOH, including substance use, digital health, and health systems science. Our current D43 Training Program
for Strengthening Research Capacity in Non-Communicable Diseases in Vietnam (2019- 2025) accomplished
its two aims: (1) we developed a program in NCDs including the establishment of a new Postdoctoral fellows
training program and a new Master’s program in Epidemiology in English; and (2) we established an NCD
administrative Research Unit at HMU in close collaboration with the VMOH. Our trainees (n =24 ) have conducted
research in diverse array of critical and public health areas, including aging, cardiovascular disease, cancer,
men’s health, pediatrics, HIV, clinical genetics, and health policy. During the past five years, our trainees have
published 85 papers in international (23 first author) and 82 in Vietnamese peer-reviewed journals (25
first author). Our trainees have also received extramural funding (n = 10) from domestic and international
sources (eg. NIH fellowships, NIH grants) and gone on to matriculate in doctoral programs (n =3).
The Specific Aims of the newly proposed STRIVE-NCD training program are to: Aim 1. Expand the
existing Postdoctoral Scholars (PS) Programs to include: (a) a Fellowship in Research and Innovation for
NCDs (FIND-PS), (b) a Substance Use Research and Education Initiative (SURE-PS), and (c) a Digital Health
and Health Systems Science Program (DASH-PS). Aim 2. Build the foundation for long-term impact,
continuity, and sustainability by establishing: (a) a Mentorship Engagement and New Training Program
(MENT) for emerging mentors, (b) a Support and Enhancement for Emerging Scholar Development (SEED). We
will also strengthen the administrative capacity of the NCD Research Unit to meet the growing needs of long-
term training and research activities. STRIVE-NCD will further bolster the country’s research capacity, including
the pool and expertise of junior investigators, and expand to other pressing areas of clinical and public health
concern. With 10 years of sustained collaboration, our team includes accomplished scientists from the VMOH,
HMU, and UMass Chan who are serving in leadership roles at their institution and in our current NIH-funded
work. For several NIH-funded clinical trials, the VMOH has committed to sustaining proven interventions as part
of the national public health infrastructure, and this robust research portfolio provides a strong foundation for
hands-on experience of STRIVE-NCD trainees.

Public health relevance
Narrative. We propose a renewal training program entitled “Strengthening Training and Research Initiatives for Vietnam to Effectively Managing Non-Communicable Diseases (STRIVE-NCD)”. Vietnam has been facing an increasing burden from Non-Communicable Diseases (NCDs) over the last several decades, with notable increases in morbidity and mortality from cardiovascular disease, cancer, chronic lung disease, and diabetes. We propose to further enhance and strengthen this capacity by developing innovative strategies for primary prevention and more optimal treatment approaches and expanding our existing program to other needed areas as articulated by the Vietnam Ministry of Health.